tRNA in codon usage

PROJECT SUMMARY: Codon usage is an important regulator of gene expression of each genome. In the
degeneracy of the genetic code, proteins can be coded in multiple ways using different sets of synonymous
codons, which are not translated equally. Each codon makes distinct demands on the supply of the tRNAs with
the matching anticodons. The quality of a codon-anticodon pairing is determined not only by the availability of
the tRNA, but also by the epigenetic modifications to the tRNA, to the mRNA codon, and to the rRNA that
reads the pairing interaction. Importantly, epigenetic modifications to tRNA, mRNA, and rRNA, the three major
types of RNAs, have emerged as the frontier for understanding expression of the genetic code. Each
modification in an RNA is catalyzed by a dedicated enzymatic pathway post-transcriptionally without altering
the genome. While all modifications must converge at the ribosome during protein synthesis, this concept is
under-appreciated and rarely tested. In the past 5 years, we have developed tools and reagents to test this
concept. In the next 5 years, we will focus on three areas, using the experimentally trackable E. coli as a
model, where post-transcriptional modifications in all three major types of RNAs have been identified. Notably,
while modifications to tRNA and rRNA are well known in E. coli, modifications to mRNA were just discovered,
representing an unexplored frontier that will impact on our understanding of bacterial survival and resistance to
antibiotics. In the first area, we will extend our study of the N1-methylation of guanosine at position 37 (m1G37)
on the 3'-side of the tRNA anticodon. While m1G37 is conserved in evolution and is essential for life, we have
successfully isolated E. coli mutants that suppress the loss of viability upon deletion of m1G37. Mechanistic
studies show that these suppressors now require a minor isoacceptor tRNA for survival. We will determine
whether this is a general principle of bacterial survival upon loss of m1G37 by testing two pathogenic bacterial
species of importance (Vibrio cholerae and Acinetobacter baumannii). We will also define the genetic
mechanism of survival of one of these suppressors. In the second area, we will study the adenosine-to-inosine
(A-to-I) editing, which occurs both at the wobble position of bacterial Arg(ACG) tRNA and at Y29 (tyrosine at
position 29) of hokB-mRNA, which codes for a self-killing toxin that guides bacteria to persistence in nutrient
starvation. We will determine how the A-to-I editing in Arg(ACG) changes the decoding specificity on the
ribosome, how the editing in hokB-mRNA is regulated, and whether E. coli virulent strains exhibit a different
editing profile than a non-virulent strain. In the third area, we will study the di-methylation marks m62A1518-
m62A1519 in the 16S rRNA of the E. coli ribosome as a checkpoint for quality control of protein synthesis. We
will address how loss of the checkpoint confers resistance to the antibiotic kasugamycin (KSG) and how the
checkpoint interacts with m1G37-tRNA and with the inosine-modified Arg(ACG). We aim to obtain an integrated
view of how post-transcriptional modifications in these RNAs confer the quality of life at the limit of cell survival.

Public health relevance
PROJECT NARRATIVE The speed and quality of translation of each codon is regulated by post-transcriptional modifications in the tRNA for the codon, in the mRNA codon itself, and in the rRNA that reads the anticodon-codon pairing interaction. However, we do not have an integrated view of how these modifications, when converged on the ribosome, “talk” to each other. We will use E. coli as a model to elucidate the principles of how modifications in tRNA, mRNA, and rRNA, separately and together, control the flow of genetic information transfer from DNA to RNA to protein as a new mechanism to inform novel strategies to combat clinically relevant bacterial infections.